Escherichia coli invasion of brain endothelial cells

E. coil K1 is the most common gram-negative organism causing neonatal meningitis. One of the least understood issues in the pathogenesis of this disease is how circulating E. coil K1 crosses the blood-brain barrier (BBB) to cause brain injury. We have demonstrated in the in vitro and in vivo models of the BBB that E. coil K1 invasion is a complex process mediated by multiple E. coil invasion determinants, among which the 50-kDa protein encoded by ibeA is unique to E. coil KI. A bovine IbeA-binding protein (IbeABP) has been isolated by IbeA-affinity chromatography from brain microvascular endothelial cells (BMEC). The ibeA locus is a genetic island of meningitic E. coil (GimA) containing 15 genes, which consist of four operons, ptnlPKC, cglDTEC, gcxKRCI and ibeRAT. IbeA is an important virulence factor contributing to E. coil Kl-mediated invasion in BMEC and the 14 other genes may involve in energy metabolism. The regulatory protein IbeR carrying a as4-interaction domain belongs to the NtrC/NifA family of transcriptional activators. It has been shown that anaerobic growth and glucose greatly enhanced E. coil K1 invasion of BMEC. Based on these results, we have hypothesized that the ibeA locus-mediated invasion and energy metabolism are coordinate events in pathogenesis of E. coil K1 meningitis. Interactions between IbeA and its receptor induce cellular responses that are required for E. coil entry of BMECs. Invasion gene expression is regulated by the genetic island GimA including IbeR and environmental signals. Our hypothesis will be tested through the following Specific Aims. (1). To examine how IbeA contributes to E. coil K1 entry of human BMECs. (2). To further characterize the role of IbeABP in E. coil K1 invasion of human BMEC. (3). To determine how E. coil K1 invasion gene expression is regulated by the IbeR and environmental signals (glucose and oxygen tension).